Research Supplements to Promote Diversity

On-chip multiplex detection of periodontal pathogens
by Raman imaging at single cell level
Project Summary:
Periodontitis is initiated by complex bacterial interaction in tissues surrounding the teeth.
Periodontal pathogens accumulate in periodontal pockets and induce periodontal destruction in
a cooperative manner, leading to gingival inflammation, soft tissue destruction, and bone
destruction. These pathogens can serve as biomarkers to inform periodontal status. Surface-
enhanced Raman spectroscopy (SERS) has emerged as a powerful label-free detection tool to
discriminate bacterial phenotypes due to the Raman signatures of their unique molecular
composition. To facilitate SERS utility in clinical applications, it is imperative to develop a platform
that warrants simple and universal sample preparation method with minimal technical demand.
We address this critical need in this study by pre-loading Ag nanoparticles (Ag-NPs) on all
bacterial cells in a sample in a one-pot reaction. The reaction is quick and no species-specific
label is needed. Following the parent grant's microbial compartmentalization concept, the
pathogens will be disseminated to microchambers that are interconnected by parallel
microchannels. By design, each microchamber accommodates one cell. Ag-NP enables the
collection of well-resolved Raman spectrum at a single-cell level (Aim 1). Machine learning in
combination with the snap-shot hyperspectral imaging approach will enable confident
identification and enumeration of pathogen species with spatial resolution to facilitate on-chip
multiplex detection (Aim 2). This is a versatile detection method that can be integrated on a
portable sensor device as proposed in the parent grant.
Integrating with other components of the parent grant, this research contributes to the
development of a prototype salivary sensor that will offer detailed medical data from frequent and
progressive monitoring, and it will be an effective tool for future personalized medicine and is
expected to dramatically improve the patient's overall health. In addition to technical training, the
predoctoral student will gain experience through engaging in interdisciplinary collaborations,
providing him with insights into the intricacies of workflow within an interdisciplinary project and
the pivotal role that each specialty subject would play in supporting research in diverse fields,
preparing him to become capable of tackling multifaceted challenges in his future career.

Public health relevance
Project Narrative: This Research Supplement is to extend the parent grant's research on the sensing modality of detecting periodontal pathogens in saliva by establishing a simple, universal single-cell detection method. With Ag nanoparticles pre-loaded to all cells for Raman signal enhancement, employing advanced machine learning and new hyperspectral imaging approach, multiplex detection on a microfluidic chip will be achieved. The research provides a unique opportunity for a predoctoral candidate to engage in translational research, interdisciplinary training, and inspire him to become a prominent leader for a successful career in health science and industry.